Ecological immunology of a flea vector (Ctenocephalides felis)

PROJECT SUMMARY/ABSTRACT
Fleas are obligate vectors of bacterial pathogens that cause severe diseases in humans, including murine typhus
and bubonic plague. To resist or limit infection, fleas possess an innate immune system that provides defense
against microbial invasion and colonization. However, in their natural habitats, flea populations are made up of
individuals that differ not only their genetic background, but also in regard to factors such as sex, age, diet,
infection history, gut microbiota, and exposure to environmental stressors. These non-genetic factors have been
shown to have important consequences on the outcome of infection in other disease vectors; yet, no studies to
date have addressed the impact of these ecological parameters on flea immune responses. The proposed
research aims to fill these knowledge gaps in flea ecological immunology, with the primary goals being to
determine the intrinsic factors that affect the antibacterial response in adults, and to determine the effect of larval
ecology on subsequent infections as adults. Specifically, we propose to compare the strength of immune defense
mechanisms in adult cat fleas (Ctenocephalides felis) based on sex, age, and infection history (Specific Aim 1),
as well as following larval exposure to food quantity, larval density, and insecticides (Specific Aim 2). This project
will provide valuable insight into the variability of flea immunity under natural conditions, which can directly affect
pathogen transmission dynamics and alter disease prevalence outcomes within a vector population. Data arising
from this project could aid in the development of novel strategies to control the spread of flea-borne pathogens
to humans.

Public health relevance
PROJECT NARATIVE It has been hypothesized that insect immune responses can be harnessed to control the spread of vector-borne diseases. Although fleas transmit numerous deadly and debilitating diseases to humans, relatively little is known about how they defend themselves from infection under natural conditions. The proposed research aims to address basic entomological questions related to flea ecological immunology, which could aid in the development of novel control strategies for flea-borne diseases.